Defining the Role of Astrocytic Lysosome trafficking and Exocytosis in Regulating Synapse Maturation

ABSTRACT Astrocytes are critical components of synapses, providing essential metabolic support, regulating
synapse formation, and modulating synaptic firing. The mechanisms by which astrocytes support synaptic
function are largely unknown. In response to neuronal activity, astrocytes produce local calcium spikes that
promote the release of neuroactive transmitters, such as ATP. ATP release from astrocytes is essential for
sustaining neuronal firing, synapse maturation, and plasticity. Prior work in monoculture astrocytes revealed that
lysosomes undergo robust exocytosis and release ATP in response to glutamatergic stimulation. How this
process of lysosome exocytosis occurs within astrocytes that are synaptically connected with neurons
remains unknown. Even less is known regarding the cytoskeletal organization that impacts the trafficking and
transport of lysosomes in astrocyte branches. However, perturbances in the cytoskeletal organization of
astrocytes impairs calcium responses and reduces ATP release, leading to impairments in neurodevelopment
and early onset neurodegeneration. These data suggest that the regulation of lysosome trafficking is
essential in maintaining astrocyte-neuron interactions. My preliminary data suggests that neuronal firing
restricts the mobility of lysosomes in astrocytes and may promote lysosome exocytosis in astrocytes in a non-
cell autonomous manner. Specifically, I find that in developing astrocytes, lysosomes display short-range
bidirectional motility that is dampened by synaptic activity. However, in mature astrocyte branches, lysosomes
are largely immobile, and their motility is insensitive to synaptic activity. Pharmacological perturbations to the
cytoskeleton revealed that this anchoring of lysosomes in astrocytes is likely due to a switch from microtubules
to actin filaments. Based on these data, I hypothesize that as astrocytes mature, lysosomes accumulate in
perisynaptic compartments due to a switch from microtubule to actin cytoskeletal tracks. This localization may
position lysosomes to undergo activity-dependent secretion, releasing contents that support the maturation of
synaptic compartments. To test this hypothesis, I will (Aim 1) define mechanisms of lysosome positioning in
astrocytic branches and (Aim 2) determine the impact of synaptic activity on lysosome exocytosis in astrocytes.
I will use a robust system to coculture neurons and astrocytes to investigate the dynamics of this process with
high spatiotemporal resolution using cutting edge methodology in live cell imaging. Combined, these aims will
define lysosomes in astrocytes as signaling organelles that play crucial roles in synaptic maturation. Knowledge
gained from this study will elucidate new molecular pathways for how astrocytes are key components of the
tripartite synapse and enlighten our understanding of how astrocyte dysfunction may contribute to synaptic
deficiencies in neurodevelopmental and neurodegenerative disorders.

Public health relevance
Project Narrative: Astrocytes provide essential support for synapse development, plasticity, and signaling; yet little is known about the basic cellular and molecular mechanisms that govern this function. This proposal aims to investigate the lysosome as a critical signaling organelle at astrocyte-neuron synapses and define mechanisms of lysosome trafficking in astrocytes. Knowledge from this study will enlighten how astrocyte dysfunction may contribute to synaptic deficiencies in neurodevelopmental and neurodegenerative disorders.